Stem cell reprogramming for joint preservation to alleviate pain and promote function

Abstract
The overall objective of this application is to identify an unlimited supply of immunomodulatory cells that can
consistently promote joint tissue preservation when injected in clinically relevant surgical models of osteoarthritis
(OA). This is motivated by the critical need to develop novel strategies to alleviate pain and promote function
through rehabilitative strategies aimed at preserving joint cartilage in Veterans that suffer from OA. Veterans are
three times more likely to develop OA than civilians in part due to the high demands and joint injury risks
associated with military service. Distressingly, our Veterans are also more likely to abuse narcotics and opioids
that could provide temporary pain relief but lead to devastating long-term consequences. Intra-articular injections
of mesenchymal stromal cells (MSCs) are now standard of care for knee OA in a variety of orthopaedic clinics,
with increasingly well-documented data showing their efficacy. Yet, clinical care requires point-of-care harvest
of autologous cells that may have reduced quality in older and/or osteoarthritic individuals.
Here, we propose to leverage critical data obtained from our recently completed randomized controlled trial
(NCT03818737) that suggest the superiority of autologous bone marrow derived-MSCs (BM-MSCs) to relieve
clinical OA pain over cord tissue MSCs in responder patients. Furthermore, we provide preliminary data in a rat
OA model that BM-MSCs provide greater tissue preservation and pain relief than allogeneic sources, but donor
variability remains a barrier to a consistent therapeutic benefit. To overcome these limitations, we began using
MSCs derived from induced pluripotent stem cells (iMSCs) as therapeutic immunomodulators of joint
inflammation in preclinical models of OA. We found that iMSCs from healthy articular chondrocytes (AC-iMSCs)
elicited excellent chondro-protection and analgesia, comparable to somatic BM-MSCs.
Based on the above, we posit the Central Hypothesis that a somatic cell-derived iMSC product that exhibits
robust immunomodulatory action in vitro will yield an unlimited supply of allogeneic medicinal cells that
will reduce pain, improve function, and slow tissue degradation in a clinically relevant model of OA. To
test this hypothesis, we will first establish the immunomodulatory potential of iMSCs derived from bone marrow
MSCs and articular chondrocytes compared to somatic cells (Aim 1). We will then ascertain the in vivo efficacy
of the iMSCs with the most immunomodulatory potential using our rat MMT model of OA (Aim 2). Finally, we
plan to validate the therapeutic potential of the most effective iMSCs in a clinically relevant pig model of OA (Aim
3).

Public health relevance
Project Narrative: Veterans are more than three times as likely to develop osteoarthritis (OA) than the civilian population. Intra- articular injections of autologous cellular products are becoming standard of care for joint preservation as their efficacy to elicit pain relief and promote function is increasingly reported. However, variability across donors, donor site morbidity for harvest, and their limited availability remains significant limitations. In this proposal, we propose to develop medicinal cells from various sources that are unlimited in supply and test their efficacy to inhibit pain and promote joint cartilage function using clinically relevant animal models of OA. The completion of this proposed work will identify a cell product capable of consistently promoting joint cartilage preservation with the long-term potential to treat Veterans suffering from OA.